Regulation of prefrontal cortical circuit function and reward-seeking behavior by stress-induced dendritic spine remodeling

Project Summary / Abstract
Depression is by definition a fundamentally episodic form of mental illness featuring discrete symptomatic
periods, interposed between periods of apparent wellness. The neurobiological mechanisms driving the
induction, remission, and recurrence of depressive episodes over time are not well understood, especially at
the circuit level, but converging evidence indicates that synaptic remodeling in prefrontal cortical (PFC) circuits
plays an important role. Still, despite decades of pioneering work in this area, a mechanistic understanding of
how postsynaptic dendritic spine remodeling contributes to changes in PFC circuit function and depression-
related behaviors over time remains elusive. To date, most studies have relied on cross-sectional comparisons
of spine density in fixed tissue at a single time point, obscuring dynamic effects on spine formation,
stabilization, and pruning—distinct processes with differing implications for identifying new treatment targets.
How stress affects dynamic spine remodeling processes differently in the female PFC is also unclear, despite
the fact that sex is a critical risk factor for stress-related psychiatric disorders. Perhaps most importantly,
whether spine remodeling causes or merely correlates with behavioral changes and altered function in specific
PFC circuits is unknown. This proposal will investigate how stress-induced spine remodeling in the PFC
contributes to anhedonia, a core feature of depression. PFC circuits support reward-seeking behavior by
mediating action valuation computations, which integrate information about the magnitude of an anticipated
reward and the expected effort required to obtain it. Leveraging newly developed optogenetic and 2P imaging
methods for visualizing and manipulating spine dynamics and defining their effects on circuit function, we will
investigate how spine remodeling in topologically defined projection neuron subtypes contributes to the
induction, remission, and recurrence of anhedonic behavioral states. We will use a two-hit stress model,
whereby early life stress (ELS) induces heightened stress sensitivity and sex-specific effects on HPA axis
reactivity in adulthood, imaging PFC projection neurons before and after chronic stress and longitudinally
during recovery. Reward-seeking behavior will be quantified in a 2P imaging-compatible action valuation task,
in which we can independently manipulate anticipated reward magnitude and expected effort. We will test the
hypothesis that stress disrupts action valuation by selectively eliminating dendritic spines and disrupting
multicellular ensemble activity in PFC projections that play a critical role in encoding reward predictive cues.
Next, we will test pharmacological and circuit-based strategies for promoting stress resilience and recovery.

Public health relevance
Project Narrative Depression is an extremely common and disabling form of mental illness defined by discrete episodes of low mood and anhedonia interposed between periods of wellness. This project will investigate how stress effects on the remodeling of connections between cells in specific brain circuits contribute to the induction, remission, and recurrence of anhedonic behavioral states. These studies will advance our understanding of the circuit-level mechanisms underlying a core feature of depression and evaluate strategies for promoting stress resilience and recovery.